Membrane Protein Complexes in the M. Tuberculosis Divisome: Structures and Interactions

PROJECT SUMMARY
Tuberculosis (TB) has inflicted a quarter of the worldwide population and caused 1.6 million deaths in 2021
alone. However, there have been no new classes of TB drugs developed since the 1970s. New therapies are
desperately needed as multi-drug and extensive drug-resistant TB cases have increased rapidly. The primary
reason for drug resistance is latency, where the causative agent, Mycobacterium tuberculosis (Mtb), remains
non-proliferative in the patient’s body. Understanding the cell division process in Mtb through structural
characterizations of the participating protein complexes is critical for designing resistance-breaking therapeutics
and is the objective of this project. Bacterial cell division is mediated by the divisome, which comprises dozens
of proteins spanning the cytoplasmic membrane and the periplasm, with the Z-ring as the scaffold. We recently
discovered that the cytoplasmic N-terminal region of Mtb FtsQ binds FtsZ, which is the protomer of the Z-ring,
and hypothesized that FtsQ may stabilize the curvature of the Z-ring and anchor the Z-ring to the inner
membrane. In E. coli, FtsQ forms a ternary complex with FtsB and FtsL to activate enzymes that are responsible
for the synthesis of cell walls. However, the amino-acid sequences of the Mtb FtsQ, FtsB, and FtsL are distinct
from their E. coli analogs, suggesting different structures and functional mechanisms. The Specific Aims of this
project are: (1) to investigate the structural and functional roles of the FtsQ-FtsZ interaction; (2) to characterize
the structure, interaction, and function of the FtsQ-FtsB-FtsL complex; and (3) to develop 17O NMR for probing
membrane protein interactions. This work will employ advanced solid-state and solution NMR combined with
molecular dynamics simulations to characterize protein complexes in native-like membrane environments. The
proposed functional studies will establish crucial connections between structural insights and biological activities,
with profound implications for drug resistance. Our interdisciplinary team, with expertise in NMR spectroscopy,
computational biophysics, and microbiology, is ideally positioned to accomplish the proposed studies. This
research will yield critical knowledge on the cell division process in Mtb and help identify drug targets for effective
therapeutic strategies to address the TB epidemic. The new methodologies that we will develop represent the
frontier of protein structural biology.
1

Public health relevance
NARRATIVE Mycobacterium tuberculosis is the most infectious bacterium to date, inflicting a quarter of the worldwide population and causing 1.6 million deaths in 2021 alone. Both the occurrence and the treatment cost of drug- resistant TB have increased rapidly, and the primary reason for drug resistance is latency, where the bacterium remains in a non-proliferative state. The proposed work will lay the foundation for designing resistance- breaking therapeutics through structural characterizations and functional studies of key protein complexes involved in cell division. 1